Investigating replication gap suppression in distinct modelsof chemoresistant BRCA mutant cancers

Project Abstract
The overall goal of this proposal is to gain a new understanding of the factors that contribute to
chemoresistance in BRCA1 and BRCA2 (BRCA) mutant hereditary breast and ovarian cancers (HBOC).
Currently clinical strategies rely on chemotherapies and poly (ADP-ribose) polymerase inhibitors to control
malignant disease. Unfortunately, tumor chemoresistance frequently occurs which necessitates studies that
uncover the critical factors leading to chemoresistance. We have recently discovered chemoresistance is linked
the single-stranded (ss)DNA gap suppression in multiple models of HBOCs and patient tumors. Our work has
generated a paradigm shift that ssDNA predicts sensitivity whereas gap suppression predicts resistance. To
expand upon our model that ssDNA gaps are the sensitizing lesions in BRCA cancers, I propose two aims. In
Aim 1, I will determine if an axis of chemoresistance in BRCA1 deficient cancers, linked to restored homologous
recombination, is instead mediated by gap suppression. In Aim 2, I will determine if gap suppression in a
chemoresistant BRCA2 tumor model is linked to the activation of translesion synthesis and how translesion
synthesis can be overcome to resensitize these cancers. Together, these aims increase our knowledge of the
basic factors that lead to chemoresistance in the clinic and will provide new insights into the vulnerabilities unique
to BRCA deficient cancers. Moreover, by identifying unique factors contributing to chemoresistance, we will
develop an understanding for potential druggable targets and biomarkers for future personalized chemotherapy.
Existing chemotherapies are constrained by their side-effect profiles, often taxing patients' tolerance and
potentially inducing secondary malignancies. Generating a new understanding of the factors contributing to
chemoresistance is pertinent to improving patient outcomes.

Public health relevance
Project Narrative Chemoresistance is a major clinical hurdle in hereditary breast and ovarian cancers. This proposal seeks to further our understanding of chemoresistance by investigating how chemoresistant BRCA1 and BRCA2 tumor models suppress replication associated single-stranded DNA gaps. This knowledge will aid the understanding of factors critical to chemoresistance and highlight targets for future pharmaceutical approaches.